Interdisciplinary Training in Transplantation Biology

PROJECT SUMMARY/ABSTRACT
The pressing need to improve understanding of the mechanistic basis of transplant rejection and tolerance and
to translate advances to the clinic, provides exciting opportunities for cutting-edge basic and translational
scientists. There is a critical need for training programs that optimally prepare the next generation of
transplantation researchers. With strong institutional support, the University of Pittsburgh School of Medicine
(UPSOM) Starzl Transplantation Institute (STI) provides a unique academic environment, with an outstanding
translational research base and culture, conducive to strong and comprehensive, broad-based training of young
basic scientists and physicians in transplantation biology. Our established and proven Interdisciplinary Training
Program in Transplantation Biology (TPTB) is very clearly delineated from other (successful) training programs
at UPSOM. Our training program helps ensure that highly-trained investigators, strongly focused on
transplantation, are available to assume leadership roles in academia, industry and government-affiliated
research. Our highly-accomplished and well-funded participating faculty, further strengthened since our last
renewal application by research leadership recruits, particularly in bone marrow and lung transplantation, have
a very successful record of productive collaboration and strong commitment to training of young investigators.
Expertise includes immunogenetics, ischemia-reperfusion injury, antigen-presenting cell, T and B cell biology,
stem cell biology, tolerance induction, liver immunology, transplant infectious disease, chronic rejection, allo-
and xenorecognition, xenotransplantation and human transplant immunology. A unique feature of our Training
Program is that investigations range from those in invertebrates (a trainer on the grant is expert in invertebrate
allorecognition) and rodents to non-human primates and humans. Over three funding cycles our trainees have
been very successful, publishing in leading journals, and in obtaining individual research fellowships, recognition
and career development awards and faculty positions. Our goal is to produce outstanding, potentially
independent investigators, highly conversant with fundamental and translational questions in transplantation
biology and equipped with appropriate investigational, survival and career development skills. Pre-doctoral
trainees are selected from graduate students enrolled in the Program in Microbiology & Immunology and the
Interdisciplinary Biomedical Graduate Training Program at UPSOM, including those in the medical scientist
training program, who seek a PhD in transplantation biology. Based on successes achieved during the three
previous funding periods of this Training Grant and the availability of well-qualified applicants, we request support
of 2 pre-doctoral trainees in year 16 and subsequent years. Postdoctoral trainees with MD, PhD, or dual degrees
will be selected based on their outstanding potential and supported for 2 years. Support is requested for 2
postdoctoral trainees in year 16 and subsequent years. Our training faculty are strongly committed to ensuring
appointments of members of underrepresented diversity groups to the grant.

Public health relevance
PROJECT NARRATIVE Training students and fellows in transplantation biology provides the next generation of scientists who will improve understanding of transplant rejection and acceptance, and develop treatments to reduce patients’ dependence on immunosuppressive drugs. This training program teaches young scientists the necessary skills to develop research careers in transplantation with a strong emphasis on immunology and cell and molecular biology.